Understanding the mechanism of bone marrow stromal cell-mediated protection of FLT3-ITD AML from FLT3-targeted therapy

PROJECT SUMMARY
Acute myeloid leukemia (AML) is the most common adult acute leukemia and accounts for 20% of childhood
leukemias. Internal tandem duplication (ITD) mutations in FMS-like tyrosine kinase 3 (FLT3) are among the
most common mutations in AML and are particularly associated with a poor prognosis. FLT3-ITD causes
constitutive activation of FLT3 and the strong evidence that activated FLT3 drives leukemogenesis has led to
the development of several FLT3-targeted inhibitors. Among these, the most potent and selective FLT3
inhibitor is AC220 (Quizartinib), which demonstrated a 44 % complete remission rate in AML patients harboring
FLT3-ITD. However, remissions achieved by AC220 were short-lived, and AC220 treatment resulted in much
more effective clearing of peripheral blasts than bone marrow blasts, implicating the bone marrow
microenvironment as an important contributor to drug resistance. Indeed, it has been shown that bone marrow
stromal cell factors can mediate resistance to the cytotoxic effects of FLT3 inhibition. Previous studies from our
lab have shown that FLT3 inhibition by AC220 impairs glutathione (GSH) metabolism and induces
mitochondrial reactive oxygen species (mitoROS) accumulation in FLT3-ITD AML cells, which is causative in
apoptotic cell death. In addition, genetic knockdown or pharmacological inhibition of Ataxia Telangiectasia
Mutated (ATM) or its downstream target, Glucose-6-Phosphate Dehydrogenase (G6PD), resulted in further
impairment of GSH metabolism, more mitoROS accumulation, and enhanced apoptosis upon FLT3 inhibition.
However, whether and how these metabolic alterations influence bone marrow stromal cell-mediated
protection of FLT3-ITD AML cells from AC220 treatment is not understood. My preliminary data suggest that
when FLT3-ITD AML cells are treated with AC220 in conditioned media of bone marrow stromal cells, they fail
to induce mitoROS and are protected from the killing effect of AC220, which is associated with maintenance of
GSH levels and expression of MYC and its target glutamine transporters, ASCT2 and LAT1. Similar effects are
consistently observed in a small subset of cells that are refractory to AC220 treatment in regular media.
Interestingly, knockdown of ATM or G6PD in combination with AC220 substantially reverses the protection
from cell death mediated by conditioned media. Furthermore, knockdown of ATM or G6PD in combination with
AC220 results in significant reduction of MYC expression in cells cultured in conditioned media. Performing
both in vitro and in vivo studies, I will determine if maintenance of MYC and its target glutamine transporters,
ASCT2 and LAT1 play a key role in maintaining GSH levels and bone marrow stromal cell-mediated protection
of FLT3-ITD AML cells from AC220 treatment (Aim 1). To understand how ATM and G6PD are involved in this
protection from AC220, I will determine what stromal components are responsible for activation of ATM and
G6PD, and what the essential downstream effectors of ATM and G6PD are. (Aim 2). Findings from this
research will provide new insights into the mechanism of bone marrow stromal cell-mediated protection of
FLT3-ITD AML from FLT3-targeted therapy, and potentially identify additional targets for combinatorial
therapies designed to overcome the protective effects of bone marrow stromal cells and improve patient
outcomes.

Public health relevance
PROJECT NARRATIVE FLT3-ITD+ AML is associated with a poor prognosis and AC220, a potent FLT3 inhibitor, demonstrates much more effective clearing of peripheral blasts than bone marrow blasts. This proposal attempts to understand the key mechanism of bone marrow stromal cell-mediated protection of FLT3-ITD+ AML from AC220 treatment. Proposed experiments will address molecular and metabolic mechanisms of bone marrow stromal cell- mediated protection from the killing effect of AC220, and will potentially identify novel additional drug targets for an effective combinatorial therapy. !